Core Grant for Vision Research Core 2

CORE 2: PATHOLOGY AND IMAGING
ABSTRACT
The goal of the Pathology and Imaging core is to enable investigators to obtain state-of-the art imaging
procedures to meet their research goals. Specifically, the module (1) provides tissue processing services for
both light and electron microscopy, (2) provides access to state-of-the art imaging equipment located in
institutional core facilities and in our Cores, (3) maintains image acquisition instruments and (4) trains eye and
vision researchers on how to use and develop novel imaging technologies for their individual and collaborative
research programs. It is also responsible for the collection and maintenance of tissue specimens and cell
lines.

Public health relevance
CORE 2: PATHOLOGY AND IMAGING NARRATIVE The goal of the Pathology and Imaging core is to enable investigators to obtain state-of-the art imaging procedures to meet their research goals. Specifically, the module (1) provides tissue processing services for both light and electron microscopy, (2) provides access to state-of-the art imaging equipment located in institutional core facilities and in our Cores, (3) maintains image acquisition instruments and (4) trains eye and vision researchers on how to use and develop novel imaging technologies for their individual and collaborative research programs. It is also responsible for the collection and maintenance of tissue specimens and cell lines.